Biostatistics and Bioinformatics Core

SUMMARY - BIOSTATISTICS AND BIOINFORMATICS CORE (CORE B)
The Biostatistics and Bioinformatics Core (Core B) serves as the translational catalyst for the PPG by integrating
the diverse ‘omics’ data readouts to develop systems-level mathematical models to help advance the molecular
understanding of HCMV latency and reactivation. Core B works in close collaboration with the PPG research
projects and the other cores to provide pre-processing, analysis, modeling and computational support as well
as development of timely new methods through cutting-edge computational methods development; outreach
support; and assistance with dissemination. To achieve the full potential of the PPG center, it is essential that
data be accessible—in terms of both security (i.e., having secure, ready access) and interpretability (i.e., is high
quality, contextual and information rich). Core B serves as the data steward for the PPG. The goal of Core B is
to support all aspects of the data life cycle starting at data generation. The Core B team will build upon its
extensive data management, data standardization, biostatistical, multi-omics, and bioinformatics expertise to
ensure reproducible, transparent workflows and protocols that maximize knowledge extraction.